MULTICENTER INTERVENTION TRIAL TO PREVENT INSULIN-DEPENDENT DIABETES MELLITUS

Screening first degree relatives of patients who have Type I diabetes for anti-islet cell antibodies to detect those subjects who have a moderate risk of developing diabetes in the future; further determination of the risk for Type I diabetes by examining the first phase of insulin secretion during an IV glucose tolerance test. An algorithm based on historical data will then be used to select those who have a greater than 50% risk of developing Type I diabetes; risk subjects will be randomized into an intervention study.